Co-Evolution of Pain and PTSD Symptoms in Trauma Survivors with Musculoskeletal Injury: Identifying Early Intervention Targets to Reduce Risk of Chronic Symptoms

PROJECT SUMMARY
Many types of traumatic events, such as intimate partner violence, physical assault, combat, and motor vehicle
accidents, often result in significant musculoskeletal (MSK) injuries. Individuals who experience trauma with
MSK injury are at heightened risk for developing adverse physical and mental health symptoms, including
chronic MSK pain and posttraumatic stress disorder (PTSD). Existing research has separately identified
diverse trajectories for pain and for PTSD following acute traumatic injury: some individuals recover quickly
while others experience chronic symptoms. However, no study to date has examined individual differences in
the joint co-evolution of pain and PTSD despite their reciprocal and mutually-exacerbating relationship.
Identifying subgroups of individuals at higher risk for developing chronic symptoms of one or both
conditions and differences in their treatment interests/needs can inform the development of tailored
interventions. The proposed study will leverage Dr. Park’s ongoing Mental and Physical Health Trajectories
project to a) identify distinct subgroups with unique joint trajectories of pain and PTSD following trauma with
MSK injury using multiple-process growth mixture modeling, b) assess modifiable predictors of those symptom
trajectories, and c) understand differences in treatment preferences and needs between subgroups to inform
tailored treatments. Participants (N = 411) who experienced trauma with MSK injury within the past 14 days will
be recruited via Prolific to complete surveys at five timepoints over three months to assess progression of
symptoms from acute to chronic or resolved. Mental and physical health, pain-related factors, and trauma-
related factors will be tested as predictors of joint pain and PTSD trajectories. At the final timepoint,
participants will answer brief quantitative and open-ended questions about treatment engagement and
preferences. This comprehensive approach will provide a deeper understanding of the diverse patterns of pain
and PTSD symptom progression post-injury and also examine patient perspectives that can inform optimal
treatment for each subgroup's specific needs. NIAMS’ scientific priorities of understanding biopsychosocial
factors that make an individual susceptible to the transition from acute to chronic pain and informing person-
centered tailored interventions. The fellowship’s training aims are closely linked with the goals for the proposed
research project. The individualized training plan will provide the applicant with specialized training in MSK
pain, PTSD, non-pharmacologic interventions, biostatistics, and professional development for a research
career in examining and treating comorbid pain and PTSD. The training plan will leverage existing resources
available at the applicant’s primary institution, the University of Connecticut, with collaboration and mentorship
from leading experts across the nation.

Public health relevance
PROJECT NARRATIVE The co-occurrence and mutual exacerbation of chronic pain and PTSD represents a substantial public health challenge, and thus, understanding the co-evolution of these mental and physical health symptoms in the acute aftermath of trauma with musculoskeletal (MSK) injury is urgently needed. The proposed study will leverage Dr. Park’s existing project to a) employ highly novel joint trajectory analyses to document dynamic interactions between PTSD and pain following trauma with MSK injury, b) identify modifiable predictors of those symptom trajectories, and c) characterize differences in treatment preferences and barriers between subgroups to inform tailored treatments. Results from this study promise to enhance our understanding of the complex joint trajectories of pain and PTSD during the pivotal first three months post-trauma with MSK injury, illuminating the transition from acute to chronic symptoms, and gather patient perspectives on treatments to inform personalized intervention development.